TASK ORDER 8R - CLINICAL RESEARCH UNIT (CRU) - STAFFING SUPPORT

The purpose of this severable Task Order is to provide staffing support in the areas of clinical research protocol support and patient care.